PHYSIOLOGICAL ROLES FOR NONRECEPTOR PROTEIN-TYROSINE KINASE

Our working hypothesis states that nonreceptor protein-tyrosine kinases transduce environmental signals in fully mature cells. During the current reporting period important evidence has been obtained supporting this hypothesis. Previous studies have demonstrated that multichain immune recognition receptors, such as the T-cell receptor, signal their occupancy by inducing tyrosine phosphorylation of cellular protein substrates. Type I and II receptors for the Fc portion of IgG are single chain immune recognition receptors having external, transmembrane and cytoplasmic domains. In the present study, we have investigated the possibility that upon engagement, Fc-gamma receptors induce protein-tyrosine phosphorylation. Our findings reveal increased phosphorylation of a number of proteins on tyrosine residues after crosslinking of either high (Fc-gammaRI) or low (Fc-gammaRII) affinity receptors expressed on HL60 cells. Engagement of Fc RII induced rapid tyrosine phosphorylation that decayed to basal levels by 40 min. In contrast, phosphorylation induced by Fc-gammaRI crosslinking was more delayed, peaking at 5-10 min and returning to basal levels by 60 min. Kinase assays of cellular proteins immunoprecipitated from lysates of activated cells by antibody to phosphotyrosine revealed phosphorylation of a 72 kDa molecule that was not present in lysates of resting cells. This phosphoprotein was identified as p72syk by immunoprecipitation with antibodies directed against two different regions of the syk gene product. Immunoprecipitation with antibodies directed p72syk followed by immunoblotting with anti-phosphotyrosine antibodies revealed an activation dependent tyrosine phosphorylation of p72syk. Thus, our present findings demonstrate induction of protein-tyrosine phosphorylation following engagement of monomeric immune recognition receptors and identify p72syk as a tyrosine kinase substrate involved in signalling by Fc-gammaRI and Fc RII.